Task A89: Candidate Testing in Murine Models of Fungal Infections

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.